PREDICTIVE MODEL FOR DIAGNOSIS OF LOW BONE MASS IN PERIMENOPAUSAL WOMEN

This prospective, multicenter study will evaluate the predictive value of clinical and laboratory variables for low bone mass in perimenopausal women in a primary care setting.